Scientific Information Management and Literature-based Evaluations for the NTP - Support for Report Development

A number of complex scientific reports are prepared under this contract. These documents typically consist of a mix of graphical, tabular and textual formats and must be clearly presented to articulate the intended scientific concepts, results and conclusions. In addition, these products must be accurate, internally consistent and complete. Reports being developed under this project include Developmental and Reproductive Toxicity Reports on 24HMBP, MPRP, EHMC, and BPAF, Toxicity reports on Hexachlorobenzene, Aspergillus fumigatus, resveratrol, acetoin and pentanedione, nicotine, ionic liquids, and vanadium, Technical Reports on black cohosh, alpha pinene, TCPP, phthalates (DEHP, DBP), sodium tungstate dihydrate. Keywords: document preparation